Investigating miRNA-Mediated Bone Loss from Morphine Treatment

SUMMARY/ABSTRACT
Opioids significantly decrease bone density and subsequently increase fracture risk, but preclinical studies
addressing potential mechanisms are lacking. The nervous system is a primary target of opioids through
activation of opioid receptors, and the innervation of bone, specifically by sensory neurons, is integral for bone
homeostasis. MicroRNAs (miRNA) are small non-coding RNAs that regulate gene expression and can be
secreted to affect various cell types, including bone cells. We have developed a model of opioid-induced bone
loss through systemic morphine treatment, which significantly reduced trabecular bone microarchitecture, bone
formation, and circulating miRNAs in male mice. Furthermore, several of the circulating miRNAs we identified
were also significantly decreased in the bone of morphine-treated mice and have known associations with
bone outcomes and/or opioid use. miRNA, miR-484 may be integral to reduced osteoblast mineralization
based on high expression in healthy mouse and human bone, and it targets genes relevant to osteoblasts. This
proposal will test the hypothesis that morphine suppresses neuronal miRNA expression, which impairs
sensory-osteoblast communication through changes in gene expression and contributes to overall bone loss.
In Aim 1, we will explore the mechanism of miRNA suppression by morphine through decreased biogenesis
and/or secretion within the dorsal root ganglion (DRG), which house the cell bodies of sensory neurons.
Specifically, we will treat mice with morphine for 2 or 4 weeks and determine how miRNA expression,
biogenesis, and secretion are associated with progressive bone loss. Conditioned media treatment of primary
osteoblasts from morphine-treated DRG will determine whether morphine indirectly impairs osteoblast
mineralization. In Aim 2, we will identify the specific role of miR-484 in osteoblast function through in situ
analysis of miR-484 in femora of morphine-treated mice as well as overexpression or knockdown of miR-484 in
primary osteoblasts. miR-484 gene targets will be assessed at the gene and protein level in addition to
identification of novel genes and pathways impacted by miR-484 through RNA sequencing. I will be trained and
mentored by experts in the field at MHIR and external consultants, which will support my transition to a
postdoctoral fellow focused on skeletal health. Findings will expand our understanding of opioid-induced bone
loss through neural-skeletal miRNA communication. Further preclinical studies may then develop strategies to
mitigate opioid-induced bone loss and inform clinical decisions in the face of the ongoing opioid epidemic.

Public health relevance
NARRATIVE Opioids pose a serious risk to skeletal health by compounding bone loss in patients requiring pain management, such as those with osteoporosis, as well as predispose opioid users to fracture. Preclinical studies addressing potential causes of reduced bone quality are lacking, and this will be the first proposal to delineate the role of sensory neuron-osteoblast communication via noncoding microRNAs on opioid-induced bone loss. Results will provide basic insights on the regulation of bone formation by micro RNAs that may inform clinical strategies to treat skeletal pain and monitor patients on opioids.